Development and validation of a patient-reported outcome measure to improve quality of life related to cutaneous chronic GVHD

PROJECT SUMMARY
Candidate: I am an Assistant Professor of Dermatology and Medicine at the University of Pennsylvania and a
physician-scientist with a Master of Science in Clinical Epidemiology as well as expertise caring for patients
with GVHD. I have a strong track record of published research at the intersection of dermatology, cancer, and
transplantation. With the support of this career development award, I plan to further develop my scientific
career in two ways. First, I have been struck by the substantial health-related quality of life (HrQOL) impact that
results from skin chronic GVHD (cGVHD). I plan to gain expertise in the science of measuring disease burden
and the approaches used to conduct studies that improve patient-centered outcomes. Second, I will move from
analysis of existing datasets towards the design and execution of prospective observational and interventional
studies that improve HrQOL, morbidity, and mortality for patients with skin cGVHD. Background: Skin cGVHD
is a major contributor to morbidity, mortality, and impaired HrQOL after allogeneic hematopoietic cell
transplantation. However, patient-reported outcome measures (PROs) are not routinely used to develop,
evaluate, or select treatments. PROs provide complementary information to clinician-reported measures, can
predict clinical outcomes including survival, and are required by the FDA to support labeling claims of new
therapies. The absence of a valid and reliable PRO for skin cGVHD presents a critical barrier to designing and
executing prospective studies. Without such a measure, we cannot determine whether interventions improve
the outcomes that are important to patients. Training: To achieve research independence, I require additional
training in 1) mixed methods research and consensus formation; 2) psychometric methods; and 3) design,
implementation, and analysis of prospective observational studies and clinical trials that incorporate patient-
centered outcomes. Mentors: My training and research will be overseen by Dr. Joel Gelfand, who has
extensive experience mentoring K23 awardees to successful independent research careers, and expertise in
instrument development, patient-centered research, and prospective observational and interventional studies
in chronic inflammatory skin disease. Dr. Stephanie Lee (PRO development, prospective observational studies
and clinical trials in GVHD), and Dr. Marilyn Schapira (psychometric methods, patient-centered outcomes) will
be additional co-mentors. Dr. Alison Loren (GVHD at UPenn), Dr. Eric Tkaczyk (multicenter studies in skin
cGVHD) and Dr. Daniel Shin (biostatistics) will be advisors. Research: To achieve my objective of developing
and validating a PRO for skin cGVHD, I will pursue 3 aims: 1) Generate and evaluate content validity of an
item bank for a skin cGVHD PRO; 2) Develop a skin cGVHD PRO scale using state-of-the-art psychometric
methods; and 3) Evaluate responsiveness of the skin cGVHD PRO to therapy in a single-center prospective
cohort study. I will use the findings from this K23 as the basis for future research including an R01 or U01
proposal to conduct a clinical trial with the skin cGVHD PRO as a clinical endpoint.

Public health relevance
PROJECT NARRATIVE Skin chronic graft-versus-host disease (cGVHD) is a major contributor to morbidity, mortality, and impaired quality of life after allogeneic hematopoietic cell transplantation, and the absence of a valid and reliable patient- reported outcome measure (PRO) for skin cGVHD presents a critical barrier to conducting prospective studies that evaluate whether interventions improve the outcomes that are important to patients. In this proposal set in cancer centers in the United States, I will generate and evaluate content validity of an item bank for a skin cGVHD PRO using a modified Delphi study and cognitive interviewing, develop a skin cGVHD PRO scale using modern psychometric methods, and evaluate the responsiveness of the skin cGVHD PRO to therapy in a single-center prospective cohort study. This research is of high relevance to human health because additional treatments and treatment strategies are urgently needed to improve skin cGVHD outcomes, thereby allowing patients to live better and longer after allogeneic hematopoietic cell transplantation.